Community Recruitment and Liaison Core Rio Grande Valley AD-RCMAR

Summary Community Liaison and Recruitment Core (CLRC)
Although Alzheimer´s disease (AD) disproportionally affects elderly Hispanics, they are severely
underrepresented in research studies, preventing advances in understanding of their excess ADRD
vulnerability and improving care accordingly. The Community Liaison and Recruitment Core (CLRC) of
the Alzheimer´s disease (AD)-Resource Center for Minority Aging Research (RCMAR) at University of
Texas Rio Grande Valley (UTRGV) will spearhead the Center's recruitment and retention of diverse older
adults as research participants in social, behavioral, and biomedical research, by training scholars in
theory-based approaches for engagement of older Hispanics and their families in AD-related research. In
addition, the CLRC of AD-RCMAR will strengthen existing infrastructure for dissemination and translation
of research advances impacting the engaged communities with respect to aging, ADRD, and health of
older Hispanics. The specific aims of the CLRC are: (1) Collaborate with the Research Education Core
(REC) to educate, train, and mentor AD-RCMAR scholars in theory and approach
to community engagement for minority health disparities, and assist AD-RCMAR scholars in recruiting
older Hispanics and their families in their research studies; (2) Expand community-academic
partnerships and capacity to support the recruitment and retention of older urban and rural Hispanics and
their families; and (3) Disseminate research findings to the scientific community, health care
providers and the South Texas communities served. We will achieve these aims through mentorship of
AD-RCMAR scholars, linkage of scholars with established investigators conducting community-based
research in rural and urban Hispanic populations, and community training to facilitate widespread
adoption of best practices for optimizing participation in research studies. The results will create a state-
of-the art infrastructure for researchers, health care providers, advocates and policy makers interested in
decreasing health disparities affecting older Hispanics, and in particular those affected by AD. To
accomplish these goals, we have built a team of scientists with extensive experience in community
change, community–based research, education and Hispanic populations, that involve scientists at the
UTRGV as well as the World Health Organization collaborating Center the Work Group for Community
Health and Development at the University of Kansas, and health agencies, health care providers,
clinicians and community-based organizations of the Rio Grande Valley (RGV), Texas.